Improving Management of patients at High Risk of Pancreatic Cancer

PROJECT ABSTRACT
Our overall goal is to redefine screening for early detection of pancreatic cancer. Currently, endoscopic
ultrasound and magnetic resonance imaging (MRI) is used to survey individuals at high risk of pancreatic cancer.
These tests are costly, not easily accessible and of variable yield even in high-risk populations. Using state of
the art methods, we will develop a highly specific blood based early-detection pancreatic cancer test with
sensitivity and specificity appropriate for high-risk individuals. We will couple this with innovative approaches
which will further leverage imaging, risk factor and germline genetic data to further stratify risk. We will integrate
these diverse data to more precisely guide the management of high-risk patients. The specific aims of this project
are: 1) To develop a blood based early detection screening test, PancSEEK, for populations at higher risk of
PDAC. 2) To develop PDAC risk models that integrate clinical, genomic, molecular, and imaging data to enable
personalized surveillance management plans for individuals at higher risk of PDAC. 3) To prospectively evaluate
an integrated risk model, PancDetect, and the blood-based screening test, PancSEEK, in a population at higher
risk of PDAC.

Public health relevance
PROJECT NARRATIVE Using state of the art methods, we will develop a highly specific blood based early-detection pancreatic cancer test with sensitivity and specificity appropriate for high-risk individuals. We will couple this with innovative approaches which will further leverage imaging, risk factor and germline genetic data to further stratify risk. We will integrate these diverse data to more precisely guide the management of high-risk patients and conduct a preliminary prospective validation of this combined tool, PancDetect.